Regulation of Centrosome Biogenesis, Maintenance and Function

Project Summary
Centrioles, which function as the essential template for ciliogenesis, are carefully maintained through
different levels of regulation in vertebrate cycling cells. For example, we found that centrioles are
converted to centrosomes (or the microtubule organization center) through stepwise modifications in a
process called centriole-to-centrosome conversion (CCC). CCC enables the modified centriole, or the
centrosome, to duplicate in S phase and to segregate equally in mitosis via the spindle, ensuring
centriole/centrosome homeostasis. In addition, the presence and quality of the centrosome is further
monitored by a separate surveillance program working with p53-mediated stress signaling to remove
cells that have no or defective centrosomes. Finally, during vertebrate ciliogenesis, the centrosome can
function more than just a template – centrosomes are positioned deeply inside the cells where they
organize microtubules and Golgi-mediated trafficking to regulate the spatial configuration of primary
cilia, producing a mysterious type of cilia called submerged cilia. Instead of being at the cell surface as
seen for typical cilia, submerged cilia are deliberately hidden by cells in a deep membrane invagination
for reasons completely unknown. In this proposal, we seek to understand the molecular control of CCC,
centrosome surveillance, and submerged cilia biogenesis.

Public health relevance
Narratives Centrosome and cilia dysfunction is prevalent in a wide range of diseases collectively called ciliopathy, including e.g. Bardet-Biedl syndrome, Joubert syndrome, Meckel-Gruber syndrome, polycystic kidney disease, and primary ciliary dyskinesia. However, the physiological role that these organelles play in most tissues remains elusive. A thorough understanding of the molecular pathways vertebrate cells employ to form and maintain the centrosome-cilium complex will allow for the development of therapeutic manipulations for some of these diseases.